Investigating Syngap1 as a regulator of striatal synaptic function

PROJECT SUMMARY
SYNGAP1-related intellectual disability is a neurodevelopmental disorder caused by mutations in
the SYNGAP1 gene. SYNGAP1 encodes SynGAP, which is a highly abundant protein in the post-
synaptic density of excitatory synapses. At synapses, SynGAP functions to repress downstream NMDAR
signaling and AMPAR trafficking through its inhibition of small GTPases. Translocation of SynGAP out of
the post-synaptic density is required to allow NMDAR-dependent long-term potentiation (LTP) in cultured
neurons. In the absence of SynGAP, NMDAR-dependent plasticity is unrestrained leading to alterations
in synapse strength, spine structure, and plasticity. While the functions of SynGAP have been well-
studied in the cortex and hippocampus, the striatum also exhibits high levels of SynGAP expression.
Striatal projection neurons are GABA-ergic neurons covered in a dense array of dendritic spines, which
receive excitatory inputs from the cortex. SynGAP is therefore positioned to play a key role in gating
transmission and plasticity at striatal synapses. Despite this, SynGAP’s functions in striatal neurons have
not yet been defined. Importantly, several of the major symptoms of SYNGAP1 disorder are likely to
involve alterations in striatal activity including motor developmental delay, repetitive and restrictive
behaviors, and other behavioral problems.
In this project, we will elucidate the consequences of SynGAP loss on striatal synaptic function
and determine whether loss of SynGAP from striatal neurons is sufficient to induce behavioral alterations
relevant for SYNGAP1 disorder. Specifically, we will determine how loss of SynGAP impacts striatal
synaptic development, transmission and plasticity. In addition, we will use imaging approaches to
investigate how SynGAP deficiency affects spinogenesis, spine number and morphology. To determine
whether deletion of Syngap1 from striatal neurons is sufficient to alter disease-relevant behaviors, we will
investigate how haploinsufficiency of Syngap1 in cell type-specific knock-out mice affects motor function,
habit learning, and behavioral flexibility. Finally, we will test whether restoration of Syngap1 expression
selectively in striatal projection neurons can improve synaptic and behavioral abnormalities using genetic
rescue strategies. Together, this work will 1) further our understanding of SynGAP’s functions at striatal
synapses, 2) identify the striatal cell type(s) most relevant for the manifestations of SYNGAP1 disorder,
and 3) define critical periods for the onset and rescue of disease-related phenotypes.

Public health relevance
PROJECT NARRATIVE Mutations in SYNGAP1 cause a neurodevelopmental disorder, which is associated with intellectual disability, autism spectrum disorder, and motor impairments. This research will use mouse models to investigate how mutations in Syngap1 affect communication between brain cells responsible for the selection and learning of appropriate actions. Our findings will advance our understanding of the cellular and circuit basis of SYNGAP1 disorders and can be leveraged to improve therapeutic possibilities for patients with this and related diseases.